Regulation of Corneal Keratocyte Differentiation through the Integration of Biochemical, Biomechanical and Topographic Cues

Abstract
Corneal scarring is a leading cause of blindness worldwide. Through their interactions with the extracellular
matrix (ECM), stromal keratocytes play a central role in fundamental biological processes such as developmental
morphogenesis and wound healing. Recent studies suggest that feedback from the ECM can have a significant
impact stromal cell behavior. Specifically, ECM stiffness, topography and protein composition have all been
shown to modulate keratocyte differentiation, contractility and patterning. However, there are still significant gaps
in our knowledge of how multiple stimuli are integrated to produce specific cell phenotypes. The parent R01
project focuses on the development and testing of novel 2D and 3D experimental platforms which allow us to
systematically incorporate combinations of both soluble and non-soluble cues. In particular, in Aim 1 we are
determining how substrate elasticity modulates the keratocyte response to soluble biochemical cues; in Aim 2
we are determining how substrate topography and composition modulates the keratocyte response to
biochemical and biomechanical cues; and in Aim 3 we are determining how substrate dimensionality (2-D versus
3-D) modulates the keratocyte response to biochemical, biomechanical and topographic cues.
In this proposal we propose the acquisition of a Zeiss microscope stage CO2 incubator system that will be
installed on a motorized Zeiss Axio Observer Z1 inverted microscope. This upgrade will allow us to perform live-
cell analysis, time lapse imaging, and provide us with multi-modal information. Based on experimental data
collected over the first 4 years of the project, our needs for live-cell and time lapse imaging have expanded
dramatically. This instrumentation will allow us quantitatively (i) determine and measure dynamic cell morphology
and transient cell activation information with improved temporal resolution; (ii) characterize the impact of collagen
fibril alignment and topography on keratocyte migration in response to novel wound injury models we have
developed; (iii) allow us to identify the relative roles of proliferation and migration in response to secreted and/or
immobilized growth factors and extracellular matrix proteins; and (iv) allow us to determine the effects of 3D
confinement on keratocyte migration. The acquisition of this live-cell imaging system is expected to provide
unprecedented insights into the role of key biophysical signaling pathways on the differentiation of keratocytes
(e.g. quiescent, migratory, regenerative and repair phenotypes). Knowledge obtained using these novel
constructs should also aid in the development of targeted anti-fibrosis therapies, as well as guide tissue
engineering approaches to developing stromal tissue replacements.

Public health relevance
Project Narrative Corneal keratocytes play a central role in fundamental biological processes such as developmental morphogenesis, normal wound healing, and corneal scarring. In this proposal, we request supplemental funding to acquire a microscope stage CO2 incubator system that will allow us to perform live-cell analysis, time lapse imaging, and provide us with multi-modal information. The acquisition of this live-cell imaging system will allow us to characterize interactions between keratocytes and their microenvironment in real time, and provide unprecedented insights into the role of key biophysical signaling pathways on the differentiation of keratocytes.